BRAIN CONNECTS: High-Throughput Single Cell Projection Mapping and Spine Quantification in the Primate Brain by Synaptic Barcoding

SUMMARY
The primate brain contains trillions of highly specific synaptic connections that are the building
blocks of neural computation. While tools available in rodents have begun to shed light on how
particular cell types and circuits participate in brain functions, these approaches are not
currently possible to apply to primates. Recently, our labs have developed technology that: 1)
delivers barcoded RNAs to the presynaptic and postsynaptic compartments with high sensitivity
and specificity using AAVs; and 2) allows CNS-wide transduction by AAV through systemic
injection. We will combine these innovations, together with our platforms for single-cell and
spatial transcriptomics, to systematically map the projections of thousands of midbrain
dopaminergic neurons across the marmoset brain. In addition, we will develop strategies for the
rapid and scalable quantification of postsynaptic spines in individual cells, using known
abundance in spine variation amongst the cells of the dentate gyrus as a validation. Together,
these technologies will enable the routine quantification of presynaptic and postsynaptic
phenotypes at a level of resolution and scale that has hitherto been impossible in primate

Public health relevance
NARRATIVE Synapses–the connections between neurons–are the building blocks of the brain, enabling its ability to execute so many complex thoughts and behaviors. Measuring synapses in the primate brain has been especially challenging, because of the brain’s enormous size, and relative inaccessibility. This project will develop technology to meet this critical need, providing foundational tools for uncovering the circuitry of the primate brain.